Testing the contribution of ex-Tregs to autoimmunity and cancer immunity

PROJECT SUMMARY
Insights into mechanisms of immune regulation have led to breakthroughs in treatments for cancer and
autoimmune disease. Regulatory T cells (Tregs), an immunosuppressive subset of CD4+ T cells, are the ultimate
immune regulators – acting as gatekeepers of immune responses, critically preventing autoimmune disease, but
also hindering our body’s natural immunity toward cancer. While preclinical models have clearly shown that Treg
suppression of immune responses against tumor cells can support cancer progression, the role of their
counterparts, exTregs, is incompletely understood. ExTregs arise from Tregs but gain pro-inflammatory cytokine
production and ultimately lose the expression of the master transcription factor of the Treg lineage, Foxp3. We
hypothesize that exTregs are required to promote anti-cancer immunity and autoimmunity when Foxp3+ Tregs are
depleted. Therefore, the activation of immune responses when immunosuppression by Tregs is lifted is critically
initiated and promoted by exTregs, a novel mechanism to explain autoimmunity and anti-cancer immunity after
Treg ablation. In this proposal, we will utilize a genetic Treg lineage tracing system to both monitor exTregs in situ
as well as deplete Tregs alone (standard Treg ablation) or use a new genetic model to deplete both exTregs and
Tregs simultaneously (DUAL ablation). Hence, we can test whether exTregs are required for tumor control or the
onset of autoimmune disease when Tregs are depleted. Ultimately, our findings will be of great importance to
understanding the impact of Treg ablation on the immune response and highlight the need for new strategies that
target exTregs to ameliorate autoimmune toxicities or augment anti-cancer immune responses.

Public health relevance
PROJECT NARRATIVE Regulatory T cells (Tregs) are key stabilizers of immune homeostasis. While removing Tregs may promote autoimmunity or anti-cancer immunity by removing immunosuppression, the role of their counterpart, reprogrammed exTregs that gain pro-inflammatory activity may critically contribute to these immune responses. Here we will investigate the requirement and mechanism of action of exTregs in driving cancer control upon depletion of immunosuppressive Tregs using novel genetic approaches in mice.